Sepsis diagnosis using chemically modified DNA aptamers

Summary
Sepsis is a condition in which severe infections are caused by viruses, bacteria, parasites, or fungi, resulting in
critical illness that can progress rapidly to multi-organ failure if not treated promptly. Each year, sepsis affects
an estimated 49 million people worldwide, including more than 20 million children under age 5 and nearly 5
million older children and adolescents (ages 5-19). Sepsis takes 11 million lives around the world each year,
contributing to 20% of all deaths globally and taking more lives than cancer. In the United States, over 1.7 million
people are diagnosed with sepsis each year, and an estimated 350,000 adults die from sepsis every year. Sepsis
is a “systemic inflammatory response (SIRS) to a microbial infection,” resulting in rapid breathing, rapid
heartbeat, fever, or hypothermia. When the body’s overwhelming immune response causes damage to its tissues
and organs, it can lead to severe septic shock, resulting in multiple organ failure and death. No single diagnostic
test is available to rule out non-infectious inflammation from the onset of sepsis. The culture tests to identify
disease-causing infective agents are sent to the laboratory, and preliminary results from cultures may be available
within 24 to 48 hours; results take several days. Because of its heterogeneous nature and diverse pathobiological
pathways, sepsis diagnosis can be challenging, resulting in over or under-treatment. No single diagnostic test is
available that establishes the diagnosis of sepsis or septic shock, and the ability to distinguish sepsis from non-
infectious critical illness and to predict outcome is very limited. The known biomarkers, such as CRP, IL6, IL10,
CCL2, and CXCL10, lack specificity to rule out infection as the cause of inflammation. The one exception is in the
use of procalcitonin or PCT to distinguish sepsis from non-infectious critical illness and to guide the use of
antibiotic therapy. However, the consensus is that PCT is not an effective diagnostic measurement to rule in or
rule out sepsis from infective inflammation. Therefore, the unmet need exists for a robust and specific sepsis
biomarker. Recent studies have shown that pancreatic stone protein (PSP) is a reliable, highly specific, and
sensitive biomarker for the early diagnosis of sepsis. Aptus Biosciences is creating picomolar affinity chemically
modified aptamers against sepsis biomarkers to develop an ultra-sensitive multi-analyte quantitative test. In the
SBIR Phase I Specific Aims 1), we will create chemically modified aptamers with hydrophobic modifications on
nucleobases, which are known to deliver aptamers with picomolar affinity and without compromising specificity
against specific biomarker PSP, PCT, CRP, and IL6. 2) we will screen select picomolar affinity aptamer for non-
competitive binding to target epitopes to develop an aptamer-based sandwich assay using bead-based Quanterix
Homebrew technology for ultra-sensitive and rapid detection of sepsis biomarkers. Further, we will demonstrate
the feasibility of a multi-analyte aptamer-based sandwich assay to diagnose sepsis vs healthy control samples.
This SBIR proposal promises to improve the accurate diagnosis of sepsis from infective inflammation, helping
clinicians make timely decisions to prevent complications, unwanted expensive antibiotic therapies, treatment
burdens, and hospital costs, saving lives.

Public health relevance
Narrative Sepsis is one of the leading causes of death worldwide; sepsis is a life-threatening condition that happens when the body’s immune system has an extreme response to an infection; it can result in “septic shock,” causing multiple organ failures and sometimes death, especially if not recognized early and treated promptly. Sepsis diagnosis is challenging because of its heterogeneous nature and diverse pathobiological pathways; biomarkers such as procalcitonin (PCT), C-reactive protein (CRP), and interleukin-6 (IL6) lack specificity to rule out sepsis from infection-related inflammation. Aptus is developing an ultra-sensitive multi-analyte sepsis diagnosis test to detect sepsis and inflammation biomarkers to aid in the timely and accurate diagnosis of sepsis to help clinicians with therapeutic interventions and avoid unwanted expensive antibiotic therapies and hospitalization costs, saving lives.